Barriers to and Health Consequences of Non- Pharmacological Chronic Pain Treatment among Patients Tapering Prescription Opioids in a Large Integrated Healthcare System

PROJECT SUMMARY/ABSTRACT
Significance. Long-term opioid therapy (LTOT), previously standard care for chronic pain, led to enormous
increases in opioid-related morbidity and mortality. The CDC therefore issued opioid prescribing guidelines
in 2016, which was followed by a 70% decline in LTOT in healthcare systems such as the Veterans Health
Administration (VHA). Risks of LTOT taper or discontinuation are unclear and there is limited knowledge
about the barriers to and clinical effectiveness of the treatments used to supplement LTOT taper, such as
non-pharmacological modalities (NPM). Career Development Plan. Dr. Mannes’ training program will
include seminars, workshops, coursework, and conferences to develop his skills and expertise in electronic
health record (EHR) research methods, longitudinal and causal modeling, and health services research,
which are necessary for conducting his proposed research plan and achieving his career goals of becoming
an independent health services scientist who conducts large observational studies that will inform the
clinical care of people living with chronic pain. Mentorship. A highly accomplished team of mentors who
are experts in biostatistics, chronic pain management, and substance use epidemiology, will support Dr.
Mannes’ research and training goals. Research Plan. Dr. Mannes will conduct a clinical epidemiological
study informed by Andersen’s Model of Health Service Utilization that leverages the size and scope of the
VHA EHR (~5,000,000 patients each year) to answer the following questions: 1) What are the health risks
of LTOT taper or discontinuation since release of the CDC opioid prescribing guidelines, 2) Are veterans
who taper or discontinue LTOT more likely to receive NPM? 3) What are barriers to NPM utilization among
patients who taper or discontinue LTOT? and 4) Does NPM use improve health outcomes for patients who
taper or discontinue LTOT? To answer these important questions, Dr. Mannes will utilize retrospective
longitudinal cohort and cross-sectional study designs using data from 2016-2027. Generalized linear
models and Cox-proportional hazard models with Kaplan-Meier survival curves adjusted for
sociodemographic, clinical, and healthcare facility characteristics will be used to examine associations
between LTOT taper and NPM with care termination, opioid or pain-related emergency department visits
or hospitalization, and suicide or overdose mortality. Findings from his study will inform an R01 that will be
among the first to use national, EHR data to examine barriers, uptake, and health effects of NPM using the
Transformed Medicaid Statistical Information System. Public Health Impact. Increasing access to NPM
and identifying clinically effective NPM for people vulnerable to chronic pain are high priority areas for
NCCIH. This research will provide policy-relevant information on the consequences of LTOT tapering and
NPM at a time when non-opioid therapies for chronic pain are becoming increasingly utilized.

Public health relevance
PROJECT NARRATIVE Since release of the 2016 CDC Guideline for Prescribing Opioids for Chronic Pain, over 200,000 Veterans Health Administration (VHA) patients have had their long-term opioid therapy (LTOT) discontinued despite unclear long-term health risks and limited knowledge about the barriers to, and clinical effectiveness of the therapies used to supplement LTOT taper, such as non-pharmacological modalities (NPM). This project will leverage VHA electronic health record data to provide needed information to healthcare providers, healthcare administrators, and policy makers on the health consequences of LTOT taper or discontinuation among adults living with chronic pain, barriers to receipt of NPM for veterans who taper or discontinue LTOT, and whether use of NPM affects clinical outcomes on a large scale, which is crucial information for establishing safe and effective strategies for tapering prescription opioids.